Early Identification of Neurodevelopmental Disorders with in utero MRI

Project Summary
There is a lack of longitudinal research examining neurodevelopmental trajectories spanning the fetal to postnatal
period. The ability to characterize normative within-individual brain growth across this dynamic epoch is
imperative to establishing the degree to which gestational measures can be used to predict neurodevelopmental
abnormalities in individuals prior to later symptom onset. The goal of this proposal is to characterize the relationship
between gestational and infant measures of neurodevelopment and determine the degree to which these measures
are associated both structurally and functionally across the beginning of an individual's lifespan. The proposal
leverages a dataset comprised of 229 serially imaged pre- and postnatal brain scans. Individuals received longitudinal
structural T2-weighted scans beginning at mid gestation (postconceptional day 85) continuing through birth and into
late infancy/early adolescence (postnatal 11 months) with the inclusion of postnatal diffusion-weighted imaging.
Additionally, postnatal behavioral testing was conducted at one month of age. Aim 1 will characterize multiple cortical
developmental indices (cortical folding, surface area, and volumetric expansion) across early development. Here, I
test the hypothesis that in utero measures are associated with postnatal measures within-individuals using mixed
effect modeling. Aim 2 will expand upon the previous aim to identify the degree to which gestational cortical
macroscopic measures are associated with postnatal subcortical white matter maturation (fractional anisotropy and
normalized T2-intensity), with the prediction that measures of gestational curvature will be associated with initial
postnatal white matter organizational development. Finally, Aim 3 seeks to determine whether the developmental
indices and relationships generated from the previous two aims explain individual variability in behavioral sensorimotor
development. We hypothesize that gestational measures can alone predict composite measures of behavioral
sensorimotor task performance and will be assessed using a Generalized Mixed Modelling approach. Together, these
aims will provide a wide-ranging characterization of neurodevelopment, linking pre- and postnatal
development measures longitudinally, which represent an under-studied and exceedingly important area in
developmental research. The results generated from the proposed experiments will have implications for identifying
the gestational measures best suited for early identification of neurodevelopmental abnormalities.

Public health relevance
Project Narrative In order to understand how the brain develops, both normally and abnormally, we need to gain insight into how the brain changes in the period before and after birth. My proposal seeks to characterize neurodevelopment across this important perinatal period, and provide information regarding the degree to which prenatal assessments of brain structure relate to postnatal structure and function. This work has exciting implications for identifying fetal measures useful for predicting neurodevelopmental disorders earlier than is usually possible.